Bioinformatics and Modeling Core

The overall significance of Core B is that it will provide standardized and rigorous bioinformatics
and computational modeling analyses of all the molecular changes that occur in thoracic aortic
aneurysms. Such analyses will allow each of the projects to develop a mechanistic
understanding of the molecular changes that occur and how these changes contribute to the
progression towards dissection. We anticipate such integrated analyses will help us deconvolute
how multiple chemical signals as well as physical forces interact to control functions in the cells
of the vessel wall during disease origin and progression.

Public health relevance
CB – Narrative There is substantial evidence that thoracic aortic aneurysms are a reflection of abnormal interactions of cells in the aortic media and their environment including both matrix and pressure. In this application we will define the mechanisms controlling these reactions with the intent of discovering novel points for therapeutic intervention. Core B will provide support thorough analysis of gene expression patterns for the construction of regulatory networks and development of models of select pathways and subnetworks from receptors to effector molecules.